Expedited Partner Therapy and the HIV Prevention Cascade Among MSM in Peru

PROJECT SUMMARY/ABSTRACT
Expedited Partner Therapy (EPT) offers a unique tool to combine HIV prevention and STI control through
an integrated HIV Prevention Cascade. In providing empiric, patient-delivered antibiotic treatment to the recent
sexual partners of individuals with bacterial STIs, EPT promotes partner notification, HIV/STI testing, and
treatment, and triggers the critical first step of an HIV prevention cascade culminating in uptake of
antiretroviral-based prevention methods (such as PrEP or pre-exposure prophylaxis), and ultimately a
reduction in community-level HIV transmission risk. By targeting the sexual partners of individuals with new STI
diagnoses, EPT provides an opportunity to identify nodes of active HIV and STI transmission within high-risk
sexual networks, to promote HIV testing and linkage to prevention and treatment services among these
individuals, and to potentially reducing the incidence of HIV/STI transmission within the larger population.
Use of EPT for HIV/STI control among MSM presents three key questions for future research:
i) What is the impact of EPT on biological outcomes of persistent or recurrent bacterial STIs among MSM?
ii) What is the effect of EPT on prevention cascade outcomes of partner HIV/STI testing and linkage to HIV
prevention/treatment services? and
iii) Would any observed increases in prevention cascade outcomes lead to community-level reductions in
HIV/STI transmission?
Aim 1 (Individual). To determine the effect of EPT on individual-level outcomes of partner notification and
persistent or recurrent GC/CT infection among MSM.
Aim 2 (Partnership). To assess the impact of EPT on partner-level outcomes of notification, testing, STI
treatment, and linkage to HIV prevention and treatment services.
Aim 3 (Population). To use Agent Based Modeling to estimate the impact of EPT for MSM on HIV/STI
transmission at network- and population-levels.

Public health relevance
Project Narrative Expedited partner therapy (EPT) following STI diagnosis offers a unique strategy to integrate STI control with HIV prevention among men who have sex with men (MSM). Our study uses EPT as a tool to trigger the HIV prevention cascade among at-risk MSM in Lima, Peru.